Endovascular Orifice Detection (EOrD) Device for in situ Fenestration of Abdominal Aortic Aneurysm

Project Summary
Abdominal aortic aneurysm (AAA) is a localized dilatation of the aorta and if left untreated may go on to
rupture which is associated with a 90% mortality rate. This is the 15th leading cause of death in the United
States with more than 15,000 annual deaths reported annually. When an aneurysm reaches the maximum
diameter criteria (greater than 5.0 – 5.5 cm), clinicians will intervene with either open surgery or endovascular
repair (EVAR). For complex AAA cases, a minimally invasive fenestrated EVAR (FEVAR) is preferred over
high-risk open surgery, however, fenestrated stent-grafts extend past the visceral arteries (renal, superior
mesenteric artery and celiac artery) and must be revascularized after deployment requiring the stent-graft to be
prefabricated. Currently, there is only one FDA approved fenestrated graft on the market, the Cook Zenith
Graft, that requires additional imaging for fabrication with a 6 - 8 week delivery time, costs up to 3 times more
than traditional EVAR stent-grafts and can be technically challenging when passing guidewires through the
orifices of the fenestrations. The objective of this project is to develop a medical device for endovascular
orifice detection (EOrD) which will both locate visceral arteries and perform in situ fenestration. This device can
then be applied in the use cases of AAA, ascending aneurysms, and traumatic aortic injury.
Preliminary in vitro experiments were performed to determine whether visceral arteries could be detected
through chelated sheep blood and stent-graft material using infrared (IR) waves. A scaled-up sensor array
was built using phototransistors along with an analog to digital converter to detect the reflected IR waves.
Distinct signal responses were collected while sweeping the sensor array over the orifice of the visceral artery,
confirming feasibility. After an orifice of the visceral artery is detected, we plan to create a fenestration using a
low-powered laser or mechanical puncturing mechanism that simultaneously inserts a guidewire to deploy the
bridging stents.
Our initial EOrD prototype with the proposed approach will be delivered through a catheter sheath and
tested for orifice detection, puncture, and guidewire insertion using realistic in vitro AAA phantoms and
cadavers. Continuous feedback from our clinical experts will improve design iterations to develop a final
prototype that is able to reliably and reproducibly perform in situ fenestration of stent-grafts to treat aortic
aneurysms. With our novel device, we can improve patient healthcare and reduce overall costs associated
with AAA repair.

Public health relevance
Project Narrative: The primary conduit for blood, known as the aorta, can weaken and rupture in a significant percentage of the population. Reinforcement of the weakened aorta can be achieved by placement of a lining device known as a stent, but that can also block conduits that branch from the aorta causing further problems. We are developing a new method to create holes in the stent, while within the patient, to allow passage of blood to branching conduits.